Improving the sensitivity and specificity of MRI-based biomarkers in Alzheimer's disease

Finding a cure for Alzheimer's disease (AD) is one the greatest scientiﬁc challenges of our time. There is a
growing realization that experimental treatments should target the earliest, presymptomatic stages of disease.
But the cost of conducting clinical trials in participants who may not develop symptoms of AD for years can
be prohibitive. There is a growing need for more eﬀective biomarkers of AD, particularly biomarkers of
therapeutic eﬃcacy that can detect slowing or reversal of AD-related changes due to treatment as early in the
clinical trial as possible. These biomarkers must be as sensitive as possible to disease progression and also
account for AD heterogeneity, i.e., the fact that the majority of individuals who have AD pathology also have
one or more concomitant pathologies that may aﬀect their ability to respond to experimental treatments for
AD. This proposal focuses on deriving eﬀective presymptomatic and early symptomatic AD biomarkers from
magnetic resonance imaging (MRI), the imaging modality that provides the most direct evidence of neuritic
and neuronal loss in neurodegenerative disease. Rather than propose new MRI acquisition protocols, we
focus on the most commonly collected type of MRI scan in AD research (T1-weighted 3D gradient echo scans
with approximately 1x1x1mm3 resolution) and use advanced computational analysis to quantify changes in
the subregions of the medial temporal lobe (MTL), the brain region that associated with early stages of AD
pathology as well as with early stages of multiple concomitant non-AD pathologies. Aim 1 will develop and
validate advanced algorithms that combine conventional multi-atlas segmentation with deep learning to
reliably extract small subregions of the MTL, such as Brodmann area 35, explicitly accounting for anatomical
variability in the MTL. Aim 2 will correlate quantitative digital pathology measures derived at autopsy with
antemortem MRI to discover distinct patterns of change that we hypothesize are associated with concomitant
pathologies in AD, including TDP-43 pathology, alpha-synucleinopathy, non-AD tauopathies, and
cerebrovascular disease. Aim 3 will apply deep learning to improve the sensitivity of measures of change in
longitudinal MRI, hypothetically leading to a more sensitive early marker of treatment eﬀectiveness in trials
targeting preclinical AD than existing cognitive and imaging-based measures. Taken together, improved
precision of segmentation (Aim 1), determination of spatial patterns of AD and concomitant non-AD pathology
(Aim 2), and advanced longitudinal measurement methodology (Aim 3) will optimize MTL subregional
sensitivity and speciﬁcity for the earliest neurodegenerative changes of AD, providing a potentially critical
therapeutic eﬃcacy measure to accelerate clinical trials of disease modifying treatments in early AD.

Public health relevance
Treatments for Alzheimer's disease will likely be most eﬀective if applied before patients begin to develop symptoms of cognitive decline. But clinical trials in individuals who do not yet have any symptoms of disease can take a very long time and be very costly. This project uses common magnetic resonance imaging exams and artiﬁcial intelligence tools to detect subtle changes over time in parts of the brain where damage speciﬁcally due to Alzheimer's disease ﬁrst occurs, providing clinical trials with a faster way to determine if treatments are being eﬀective.